P-QST Project: Pancreatic Quantitative Sensory Testing (P-QST) to Predict Treatment Response for Pain in Chronic Pancreatitis

ABSTRACT: Abdominal pain is the primary driver of morbidity in chronic pancreatitis (CP) and affects
approximately 90% of patients over the course of their disease with devastating effects on quality of life.
Etiology of pain in CP is multi-factorial. Patients with evidence of pancreatic duct obstruction due to stones
and/or strictures are offered invasive treatments such as endotherapy or surgical drainage to relieve pain.
However, response to invasive treatments is unpredictable, and currently no clinical tool is available to identify
patients who will respond to technically successful treatment. The lack of pain response is at least partially due
to supraspinal central sensitization (SCS), a phenomenon of neuropathic and neuroplastic remodeling resulting
from persistent pain stimuli. Quantitative Sensory Testing (QST), an investigative technique of standardized
stimulations to test nociception (the neural signaling that encodes noxious stimuli and the downstream
experience of pain), is used in other pain conditions to differentiate between patient subgroups to guide
treatment. QST has the potential to change the management algorithm of patients with painful CP. Our
preliminary data show that pancreatic QST (P-QST) can phenotype patients with CP into three groups: normal
pain processing, segmental (T10 dermatome at the pancreas) sensitization, and widespread hyperalgesia
(consistent with SCS). In this proposal, we will evaluate the ability of P-QST to predict response to invasive
treatment for painful CP, and to develop a predictive model for individualized prediction of treatment
response. Our specific aims are: Aim 1. Test the predictive capability of pre-treatment P-QST phenotype for
pain improvement following invasive treatment for painful CP. Using pre-procedure P-QST, we will phenotype
150 patients undergoing clinically-indicated invasive treatment for painful CP at UPMC and Johns Hopkins
University. Our primary outcome will be average pain score measured by Numeric Rating Scale at 6 months
post-intervention. Aim 2. Incorporate P-QST with known and suspected patient, disease, and treatment-
related factors to create a model for individualized prediction of response to invasive treatment. Using machine
learning tools, we will develop a model that optimizes the prediction of probability of response to invasive
treatment in individual patients. This will also determine the relative strength of P-QST as an overall predictor
of treatment response. Aim 3. Augment the predictive model (Aim 2) with biochemical inflammatory markers
to assess the potential to increase predictive capability for pain improvement following invasive treatment for
painful CP. The predictive model developed in aim 2 will be further strengthened by incorporating serum
neuroinflammatory markers at baseline. Our findings will be a major step toward development of
individualized prediction of treatment response following invasive treatment for painful CP. They will lay the
foundation for multicenter studies to fully define the role of P-QST in locally invasive and other treatments for
pain management for painful CP.

Public health relevance
PROJECT NARRATIVE Abdominal pain in chronic pancreatitis (CP) affects approximately 90% of patients and is the primary driver of morbidity, poor quality of life, and health care utilization. Response to currently available therapies is suboptimal and predicting which individuals will respond to invasive treatment has not been possible to date. The proposed clinical trial will evaluate the predictive capability of Pancreatic Quantitative Sensory Testing (P- QST, a novel assessment of neurosensory phenotyping) for improvement in pain (a health-related outcome) in patients with CP who are undergoing medically-indicated invasive treatment with endoscopic therapy or surgery.